Systematic identification of drivers controlling Fusobacterium and oral squamous cell carcinoma interactions

PROJECT SUMMARY
A growing body of literature suggests that a large subset of tumors, especially those along the digestive tract,
are colonized by bacteria, with one of the most well-documented intratumoral bacteria being Fusobacterium
nucleatum (Fn). Despite being a normal member of the oral cavity microbiome, Fn has been found in oral squa-
mous cell carcinomas, esophagogastric cancers, and colorectal cancers. In a manuscript currently under review,
we demonstrate that the total burden of bacteria within a tumor, which strongly correlates with intratumoral Fn
levels, is linked to an immunosuppressive microenvironment and resistance to immune checkpoint blockade.
However, it remains unknown why only some tumors accumulate bacteria, and why only some bacteria such as
Fn become enriched within tumors. In preliminary studies in head and neck squamous cell carcinomas (HNSCC),
we found that tumor cell lines exhibited distinct responses to co-culture with Fn, and that Fn strains exhibit widely
varying levels of invasiveness, indicating that there are both tumor and bacteria-intrinsic features that control
tumor-Fn interactions and, as a result, tumor severity. To comprehensively identify these features, this study will
be the first to integrate functional genomics on both tumor and bacterial cells by bringing together experts in
cancer systems biology (Dr. Daniel McGrail) and microbial functional genomics (Dr. Apollo Stacy). In Aim 1, we
will identify tumor cell determinants of Fn invasion and altered tumor cell viability. In Aim 2, we will identify
microbial determinants of Fn intracellular colonization of tumor cells. Integration of these two novel datasets will
provide the foundation to mechanistically understand and therapeutically manipulate interactions between Fn
and tumor cells.

Public health relevance
NARRATIVE Fusobacterium has been shown to promote tumorigenesis within the oral cavity and upper aerodigestive tract, as well as subsequent tumor progression and resistance to therapy. However, there remains minimal understanding of the molecular mediators controlling interactions between host and microbial cells in setting of head and neck cancer. The goal of this proposal is to comprehensively identify determinants of tumor- Fusobacterium interactions by systematic analysis of both tumor and microbial cells, which may ultimately inform therapeutic approaches to improve patient care.